Alcohol and Metabolic Dysregulation in PWH: Mechanisms Underlying Risk for Comorbidities

LSUHSC CARC RC 2
Alcohol use, which is highly prevalent among people with HIV (PWH) is a moderating
factor of risk for cardiometabolic comorbidities. Data from our New Orleans Alcohol HIV
(NOAH) Study, a longitudinal study of in care PWH, and parallel studies in the chronic
binge alcohol (CBA) administered non-human primates (NHP) show that alcohol
increases the risk of metabolic dysregulation. Our data also show that alcohol-mediated
mitochondrial bioenergetic dysfunction is an underlying mechanism of alcohol-disrupted
cellular energy metabolism and tissue injury. These findings lead us to propose that
interventions targeting mitochondrial bioenergetic function will help restore metabolic
homeostasis and as a result decrease risk of cardiometabolic comorbidities in PWH.
Previous data from the Comprehensive HIV/AIDS Alcohol Research Center (CARC)
demonstrated alcohol-associated gut dysbiosis and barrier dysfunction among PWH
enrolled in the NOAH Study. Additionally, preliminary data from CBA administered NHPs
fed a high fat high sugar diet (a.k.a. Western Diet) show a shift in plasma metabolomic
profile implicated in energy metabolism. Taken together, clinical, and preclinical data
support our overall hypothesis that metabolomic profile shifts resulting from alcohol use
and low diet quality together with mitochondrial bioenergetic dysregulation increase the
risk for age-related cardiometabolic comorbidities among PWH. Two specific aims will
test the hypotheses that 1) alcohol use in the context of a diet with low healthy eating
index shifts the circulating metabolomic profile, lowering the threshold for age-related
cardiometabolic comorbidities in PWH, and 2) alcohol-mediated bioenergetic
dysregulation contributes to multi-organ neuro-immuno-metabolic dysfunction. Proposed
studies will investigate the interaction of alcohol use and diet quality and their modifying
effects on circulating metabolomic profiles. Moreover, we will test the effectiveness of
metformin in improving mitochondrial bioenergetic function in skeletal muscle, liver,
adipose, brain, and immune cells and ameliorating alcohol-associated tissue
dysfunction. The proposed approach uses state-of-the-art techniques, combines in vivo
with ex vivo studies, and leverages our established NHP model and the longitudinal
NOAH cohort of in care PWH and HIV seronegative participants. The bidirectional
translational studies will examine mechanisms with potential for targeted therapeutic and
lifestyle interventions to alleviate alcohol-associated metabolomic and bioenergetic
dysregulation and ameliorate cardiometabolic comorbidities in PWH with alcohol use.

Public health relevance
CARC Research Component 2 (RC2) Studies proposed in RC2 of the Comprehensive Alcohol HIV/AIDS Research Center examine the mechanisms of increased cardiometabolic risk among people with HIV and alcohol use. The builds on findings suggest that the interaction of alcohol use and consumption of a poor-quality diet shifts the circulating metabolomic profile and dysregulate mitochondrial homeostasis. The proposed study will identify whether a pharmacological intervention, metformin, will help restore metabolic homeostasis and consequently, decrease risk of cardiometabolic comorbidities.